Identifying new antigens in human autoantibody-mediated disease

Project Summary. Myasthenia gravis (MG) is an autoimmune disorder affecting neuromuscular transmission.
MG patients suffer from severe muscle weakness and increased muscle fatigability due to diminished
neuromuscular signaling. MG is caused by autoantibodies that target components of the neuromuscular junction
(NMJ). The most common subtype of autoantibody-mediated MG—comprising approximately 80% of the patient
population—is characterized by pathogenic autoantibodies targeting the nicotinic acetylcholine receptor (AChR).
There is a subset of MG patients that is termed seronegative MG (SNMG). SNMG is defined by the
absence of detectable autoantibodies to the known NMJ targets. The mechanisms underlying the
immunopathology SNMG are poorly understood. Consequently, the impact on these patients is considerable;
treatment paradigms and outcomes are uncertain due to the lack of data associated with the disease
mechanisms. In addition, SNMG patients are often excluded from clinical trials in which autoantibody positive
MG patients participate.
To address this knowledge gap, we will identify immune mechanisms driving SNMG. This will be achieved
through the application of two high-throughput autoantibody-discovery technologies, both of which allow for the
screening of exceptionally large human antigen libraries. The first (termed PhIP-seq) leverages the entire human
protein catalog represented by a synthetic peptide library (peptidome), which includes all open reading frames
in the human genome. The library is presented on the surface of bacteriophages as forty-nine amino acid
peptides that “tile” or overlap each other. The second (termed REAP) affords screening of antigens displayed on
cells as full-length domains of extracellular and membrane proteins, which are often the target of pathogenic
autoantibodies. Because the antigens are expressed in live cells, protein folding into biologically relevant
conformations and post-translational modifications are included. Together these approaches complement each
other by collectively offering broad antigen coverage and presentation of biologically relevant epitope
conformations. Carefully curated SNMG patient samples from the US, Italy and Eastern Europe will be screened.
Validation of candidate antigens will be performed with independent assays used for measuring antigen-antibody
binding.
The second phase of this project focuses on defining the mechanisms these newly identified
autoantibodies use to mediate SNMG pathology. The focus will be given to antibody characteristics including
isotype and IgG subclass, followed by complement activation, receptor internalization, and interruption of
receptor/channel function. We will apply in vitro assays, which we have developed, to measure these
characteristics and mechanisms.
Overall, this study is designed to provide detailed insights into the molecular mechanisms used by
autoantibodies to facilitate the pathology of this poorly defined MG subtype. In addition to providing valuable
diagnostic biomarkers, these newly defined immune mechanisms are expected to impact treatment outcomes
by informing individualized and mechanism-specific applications of biological therapeutics.

Public health relevance
Project Narrative (relevance to public health) Seronegative MG (SNMG) is a disease subset of MG defined by the absence of detectable autoantibodies. This research is designed to better understand how abnormal immune system functioning contributes to SNMG pathology. Specifically, we will investigate whether SNMG shares immunologic features with other subtypes of MG or has immunologic features that are unique. Defining autoimmune mechanisms that underly SNMG will allow clinicians to treat the disease more effectively and guide researchers toward developing new targeted treatments.